Mechanisms for Internal Models in a Cerebellum-like Circuit

Project Summary/Abstract
Predicting the consequences of action is a vital function of the nervous system. The hypothesized neural
substrate are so-called internal models that transform information about outgoing motor commands and the
current sensory state into predictions of sensory input. Such internal models are likely critical for a wide range
of sensory, motor, and cognitive functions and their disruption has been implicated in neurological disorders
such as autism and schizophrenia. Nevertheless, it has proven challenging to understand how internal models
are implemented in neural circuits in the mammalian brain. Our prior studies were successful in developing a
detailed mechanistic understanding of how neurons in the electrosensory lobe (ELL) of mormyrid fish predict
and cancel out the sensory consequences of a simple behavior--the electric organ discharge (EOD) pulse.
However, because these studies were performed in immobilized animals, the nature of the predictions studied
was limited in scope and complexity. This renewal uses novel methods for neural recording and high-resolution
behavior monitoring in freely swimming fish to study the more complex internal models underlying the
remarkable active electrolocation abilities of electric fish. Computational modeling approaches will be used
both to rigorously define the problem facing the active electrosensory system and to generate and test realistic
circuit-level models of how they may be solved. The key components of such models, including synaptic
plasticity, recurrent and feedforward connectivity, and biophysical compartmentalization of axonal and dendritic
spikes, are common to many neural systems including the cerebellum, hippocampus, and neocortex. Hence
insights from these studies are expected to be widely relevant to understanding how internal models are
implemented in neural systems.

Public health relevance
Project Narrative Although the ability of the nervous system to predict sensory input is critical for accurate perceptions, coordinated movements, and normal cognitive function, detailed accounts of the underlying neural circuitry and plasticity are lacking. This proposal addresses this challenge by applying novel experimental approaches and theoretical modeling to an advantageous model system where neural correlates for learned predictions are highly accessible to mechanistic investigation. The detailed circuit-level models we plan to develop will provide a foundation for understanding how disruptions of predictive mechanisms contribute to neurological disorders.